Immune evasion by SARS-CoV-2: the role of HLA class I

ABSTRACT
Severe acute respiratory syndrome coronavirus-2 (SARS-CoV-2) is responsible for the current pandemic
of coronavirus-induced disease 2019 (COVID-19). Since December 2019, coordinated research efforts have
provided a wealth of critical data that have enhanced our ability to diagnose and treat COVID-19. To date,
however, much of the molecular and cellular mechanisms underlying the pathogenesis of COVID-19 remain
elusive. The genome of SARS-CoV-2 contains nine independent open reading frames (ORFs) coding for
proteins that are not essential for viral replication but seem to exert important functions in modulating host
antiviral immunity. Of these accessory proteins, the ORF8 protein stands out for its unique characteristics.
ORF8 is a highly variable protein among SARS-related CoVs. ORF8 also appears to be involved in a network
of host-pathogen interactions inside infected cells: ORF8 impairs immune pathways such as antigen
presentation, interferon type I, and nuclear factor-kB, as well as possibly activate growth pathways. A central
question is how ORF8 mediates interactions with multiple host protein targets. Towards this goal, we are
investigating ORF8 interaction with major histocompatibility class I (MHC I) molecules.
It was shown recently that SARS-CoV-2 ORF8 suppresses CD8+ T cell responses by downregulating MHC
I molecules, both in vitro and in vivo. We hypothesize that ORF8 suppresses surface expression of HLA-A and
HLA-B molecules to protect infected cells from recognition by CD8+ T cells, but spares HLA-C and HLA-E to
avoid activation of natural killer (NK) cells. The possibility that ORF8 displays a locus specificity toward MHC I
would provide a mechanism for SARS-CoV-2 to walk a fine line between adaptive and innate immunity.
Specifically, we will undertake an analysis of interactions between ORF8 and MHC I by using a panel of HLA-
A, -B, -C, and -E molecules, and also determine if ORF8 selectively downregulates MHC I in relevant cell
systems (Aim 1). We will extend these studies to ORF8 variants that have been positively selected during the
course of the pandemic and evaluate if and how these mutations affect MHC I binding and downregulation
(Aim 2). The successful completion of these Aims is expected to uncover unknown features of ORF8 and
elucidate its role in suppressing antigen presentation, as well as inform us on the selective pressure that MHC I
exerts on SARS-CoV-2. The immediate and long-term impact of our proposed research is high. This is the first
study that: (1) characterizes molecular interaction of ORF8 with a host protein; and (2) evaluates clinically
relevant ORF8 variants. By studying the immune interactions underlying ORF8-mediated downregulation of
MHC I, we will increase our understanding of how SARS-CoV-2 derails cellular immunity. Importantly, our
study will stimulate similar investigations of other ORF8-interactors, providing novel opportunities for the
development of therapeutics directed against ORF8 or its host targets.

Public health relevance
NARRATIVE To bolster their chances at survival in the infected host, viruses have evolved numerous strategies that subvert host antiviral immune functions. In this application, we will characterize the ORF8 protein, an important protein of the deadly human pathogen SARS-CoV-2 virus, that mediates unique functions in suppression of host immune pathways. Our study is significant for progress in understanding the unique biology of SARS-CoV-2, and for the development of new therapeutics.